Genomic Resource for the Yeast Saccharomyces

PROJECT SUMMARY/ABSTRACT
The Saccharomyces Genome Database (SGD) is the comprehensive resource
providing the highest quality reference information about the genome, and its elements,
of the budding yeast, Saccharomyces cerevisiae. Saccharomyces cerevisiae provides
fundamental knowledge about eukaryotic genetics, genome maintenance and
regulation, and a variety of cellular processes. SGD provides a comprehensive resource
that facilitates experimentation in biological systems, and S. cerevisiae informs genetic
medicine via annotation of human disease-related phenotypes and gene function
through functional complementation between yeast and human homologs. S. cerevisiae
is the most well studied eukaryote and the experimental literature for this yeast contains
these results. SGD synergizes results from a large variety of molecular and biochemical
assays, extending this information by assimilating the results of large-scale genomics
assays, provides connections to fungal species and model eukaryotes via orthology,
and incorporates formalized and controlled vocabularies to represent biological
concepts. SGD maintains and broadens relationships with the greater scientific
community and makes technical improvements through the development of tools and
the use of third-party software that enhances the work of scientists and educators. SGD
is a founding member of both the Gene Ontology Consortium and the Alliance for
Genome Resources, and also collaborates with many components of the NCBI and EBI.
SGD provides a substantial service organization, and maintains this service to the
scientific community, reaching out to scientists in the greater biomedical research
community to serve those who have a need for genetic information that can be provided
via the synergized results on yeast genes, their products, and their functions.

Public health relevance
RELEVANCE TO PUBLIC HEALTH, PROJECT NARRATIVE Saccharomyces cerevisiae is a model for understanding eukaryotic genetics, genome maintenance and regulation, and cellular processes. S. cerevisiae informs genetic medicine via annotation of human disease-related phenotypes and gene function through functional complementation between yeast and human homologs. SGD provides a comprehensive online resource that facilitates experimentation and computational analysis to understand fundamental biological processes.